Molecular and Cellular Biology of Cancer

Molecular and Cellular Biology of Cancer Program
ABSTRACT
The mission of the Molecular and Cellular Biology of Cancer (MCBC) Program is to facilitate basic cancer biology
research and accelerate the application of basic science discoveries into the clinic for cancer therapeutics and
prevention. To achieve this, the Program brings together world-class investigators in the areas of DNA damage
response and repair, RNA biology and therapeutics, cancer metabolism, and oncogenic signaling to generate
synergy in the war to fight cancer. The scientific themes of the Program are 1) To define the relationship among
DNA damage and repair, mutagenesis, and carcinogenesis at the molecular level and to develop therapeutic
regimens based on identified targets including molecules involved in DNA damage response, repair, and
epigenetic changes; 2) To define and characterize fundamental biological mechanisms for novel microRNAs and
long non-coding RNAs in tumor initiation, development, and metastasis as well as to develop technology based
on non-coding RNAs for cancer therapeutics; and 3) To elucidate signaling pathway alterations due to metabolic
imbalance that result in cancer initiation, cancer cell proliferation and/or death, and metastasis and to improve
the design of cancer therapeutic regimens. Targeted recruits who are nationally prominent have brought depth
and breadth to the program and include: Drs. Mark LaBarge, Kevin Morris, Zijie Sun, Debbie Thurmond, and
Xiaochun Yu. The Program is led by Drs. Binghui Shen, Professor and Chair of Cancer Genetics and
Epigenetics, and David Ann, Professor in the Department of Diabetes Complications and Metabolism in the
Diabetes and Metabolism Research Institute. In addition to its scientific goals, the MCBC Program seeks to
promote inter- and intra-programmatic collaborations, facilitate access to new technologies and resources,
create forums for scientific exchange and discussion, discover and elucidate basic cancer processes that can
be collaboratively translated to the clinic, and mentor the Program’s junior faculty.
Membership: 25 Members representing 11 academic departments
Publications: 270 total. 18.5% intra-programmatic; 39.6% inter-programmatic; 28.9% inter-institutional
Funding: $8,175,843 peer-reviewed; $3,301,399 of which is NCI funding